Individual Variations of Taste and Smell Perception in Alcohol Use Disorder (AUD)

This Institutional Review Board-approved study compares taste and smell measures and measures of alcohol intake between individuals with and without AUD. The study plans to enroll 264 individuals with AUD and 132 individuals without AUD. Enrollment is planned to open in fall 2023. The study team has been working on finalizing 3 key areas in anticipation of enrolling the first research participant, these are develop clinic operations and SOPs, design data collection tools and systems, and make study supplies and equipment ready. All operational and regulatory considerations, including staff training, are underway. Moreover, the study team has been working on recruitment and retention plans through collaborating with third party recruitment experts outside the NIH. Consequently, innovative, and more efficient ways of recruitment and prescreening have been designed and will be tested in the next 1-2 months.
This study will take place at the NIH clinical Center and is expected to be completed in 60 months from opening of enrollment. The study involves one screening visit and 2 study visits. Individuals will be screened under the NIAAA Natural History study, 14-AA-0181. Visits 1 and 2 will last approximately 4-6 hours.